Cancer Research Training and Education Coordination (CRTEC)

PROJECT SUMMARY – CANCER RESEARCH TRAINING AND EDUCATION COORDINATION (CRTEC)
Since receiving one of the first NCI designations as a Basic Laboratory Cancer Research Center, the Salk Cancer
Center (SCC) has initiated, implemented, and enhanced cancer-focused education, training, and mentoring at
all levels. The CRTEC Core is led by Geoffrey WahlGEA, Professor and SCC Deputy Director for Education and
Training, and overseen by a committee of diverse stakeholders. CRTEC ensures that SCC training, education,
and outreach activities incorporate the latest scientific advances, technologies, and methods relevant to the two
SCC Research Programs, and that these efforts are well-aligned with the SCC strategic plan. Through four
programmatic goals and two operational goals, CRTEC ensures that SCC training, education, and outreach
programs are available to the entire cancer workforce career spectrum and effectively communicate SCC
research and opportunities to the external community. The four programmatic goals are to: 1) implement high
quality research and training programs, 2) develop professional skills for career success and advancement, 3)
support fellowship and grant applications, and 4) increase the number of scientists from diverse populations in
collaboration with the Plan to Enhance Diversity (PED) Core. In support of these goals, the Core works with SCC
leadership, seminar committees, NCI T32 leadership, and Shared Resource Directors to deliver broad education
and training opportunities. These include inviting speakers to present seminars encompassing topics that span
both basic and clinical cancer science, and providing workshops on the most advanced microscopic,
transcriptomic, epigenetic, informatic, metabolic, and other techniques. To support career success and
advancement of SCC members, the Core develops and implements programs that enable SCC trainees and
faculty to stay abreast of the most exciting cancer science, to effectively relay the importance of their discoveries
to broad audiences, and to develop career skills through mentoring and coursework. The Core works with the
Grants Development Department to provide fellowship- and grant-writing training and support and to develop
multi-PI and complex grant proposals. Beyond the SCC, continued focus will be placed on outreach to K-12
schools through creative strategies, such as interactive hands-on experiences and real time social media
interactions with bench researchers. Finally, the Core collaborates with the PED Core and the Diversity, Equity,
and Inclusion Department to develop programs to expand opportunities for women, minorities, and individuals
underrepresented in the biomedical workforce. Finally, the two operational goals are to: 1) ensure robust
processes to identify opportunities and implement new initiatives, and 2) evaluate existing programs to determine
those that should be modified, expanded, or discontinued.